NEUROD1 function in SCLC fate and plasticity

Small cell lung cancer (SCLC) is a highly aggressive neuroendocrine lung tumor responsible for > 30,000 deaths
annually in the US. SCLC has a two-year survival rate of ~6% with no approved targeted therapies beyond
recently-approved immunotherapy. SCLC is initially highly responsive to chemotherapy, but rapidly develops
resistance leading to mortality in ~12 months. A major unmet need for SCLC treatment is the identification of
new therapeutic targets and treatment strategies. SCLC has historically been treated as a single disease without
patient stratification based on molecular information. We and others recently identified distinct SCLC molecular
subtypes based on expression of lineage-related oncogenic transcription factors: ASCL1, NEUROD1, POU2F3
and more controversially, YAP1. MYCL oncogene is associated with the most common ASCL1 group (~70% of
SCLC), while MYC is overexpressed in the NEUROD1/POU2F3/YAP1 subtypes (~30% of SCLC). Importantly,
we and others found that MYC-driven SCLC has unique therapeutic vulnerabilities compared to MYCL-driven
SCLC. MYC has the capacity to drive SCLC subtype plasticity, promoting ASCL1+ tumors to a NEUROD1+ and
then a YAP1+ state. MYC-induced Notch pathway activation is critical for SCLC subtype plasticity. While ASCL1
has been frequently studied, much less is known about the 2nd-most common NEUROD1+-subtype. We
hypothesize that NEUROD1 expression denotes a neuronal transcriptional state of SCLC, that NEUROD1-
mediated repression of Notch signaling is critical for this tumor cell state, and that the NEUROD1+ state has
unique therapeutic vulnerabilities. We further predict that NEUROD1 inhibition will shift tumors to
developmentally predictable non-neuroendocrine cell fates. Our objective is to determine the function of
NEUROD1 in the NEUROD1+ subtype of SCLC, to identify mechanisms that regulate subtype plasticity, and
uncover the relationship between NEUROD1 and Notch signaling. Toward this end, we created the first mouse
model of NEUROD1+ SCLC and generated mice with conditional Neurod1 loss to study its function in vivo.
Preliminary data have identified highly conserved NEUROD1 target genes. Large-scale CRISPR-based genetic
screens have identified predicted dependencies that have the potential for therapeutic targeting. Our hypotheses
will be tested in two specific aims: 1) Determine the function of NEUROD1 in MYC-driven SCLC cell fate. 2)
Determine the mechanistic relationship between NEUROD1 and Notch signaling in SCLC subtype plasticity. Our
approach is innovative because we will employ novel immune-competent GEMMs of MYC-driven SCLC, ~17
new human PDX, and single cell data from primary human SCLC. We will use state-of-the-art technologies in
single cell RNA-seq and lineage tracing in new organoid models coupled with our ChIP-seq data to
comprehensively determine the role of NEUROD1 in SCLC. This research is significant because these findings
will lead to a better understanding of SCLC molecular subtypes and ultimately facilitate tailored SCLC treatment.

Public health relevance
Small cell lung cancer (SCLC) is a recalcitrant subtype of lung cancer for which there are limited treatment options. This study will employ novel mouse and patient-derived models of SCLC as well as state-of-the-art technologies in single cell genomics and lineage-tracing to determine the function of NEUROD1 in SCLC. This work is relevant to public health and the NIH mission because it is aimed to improve the quality of life and survival of lung cancer patients by increasing our understanding of SCLC molecular subtypes and their associated therapeutic vulnerabilities.